Administrative Core

The Administrative Core assists with the administrative and financial management of the Program Project by providing the following services: 1. Day-to-day Program administration 2. Organization of Program Steering Committee 3. Coordination of Visiting Professors 4. Organization of External Advisory Committee RELEVANCE (See instructions): Program Projects are required by NIH to have an Administrative Core to assist in the management of the Project.

Public health relevance
Program Projects are required by NIH to have an Administrative Core to assist in the management of the Project.